Coordinating and Data Sharing Center - R&D of Vaccines and Antibodies for Pandemic Preparedness (ReVAMPP)

0BPROJECT SUMMARY/ABSTRACT
The global pandemic caused by SARS-CoV-2 highlighted the continual threat of emerging and re-emerging
pandemic-potential pathogens and the critical value of coordinated multidisciplinary basic and translational
research for pandemic preparedness. There is an urgent need for an integrated collaborative effort to build a
robust basic research and translational science portfolio for preparedness against high-risk viral families
including Paramyxoviridae, Picornaviridae, and Bunyavirales. The National Institute of Allergy and Infectious
Diseases (NIAID) is supporting the development of the Research and Development of Vaccines and
Monoclonal Antibodies for Pandemic Preparedness (ReVAMPP) Network to fill this critical gap. The overall
goal of this new collaborative Network, consisting of a Coordinating and Data Sharing Center (CDSC) and
six to eight Research Centers, is to collaboratively produce generalizable knowledge that enables a rapid
response when previously understudied or unknown pathogens emerge. RTI International’s well-established
track record implementing large-scale domestic and international coordinating and data management
centers, including in the emerging infectious disease ecosystem, makes us well qualified to develop and
provide Network governance, communications, and data sharing and analysis as the ReVAMPP CDSC. The
overall goal of the RTI-based CDSC is to establish and maintain an integrated Network to accelerate
discovery and dissemination of novel vaccine and monoclonal antibody strategies to prepare for the next
pandemic outbreak. To accomplish this goal, RTI proposes a CDSC organizational structure, consisting of
two interconnected teams under mPIs and a Project Director—an Administration and Leadership Team, and
a Data Management and Analysis Team. This structure leverages RTI multidisciplinary experts and will
provide ReVAMPP Centers, NIAID, and stakeholders centralized administrative, communication, and
operational support for Network-wide activities, while also establishing data sharing and analysis standards
and platforms. The Specific Aims of the RTI-based CDSC align with these two teams and will use both
established and novel innovative approaches and technologies to (Aim 1) coordinate preparatory vaccine
and antibody strategy research by establishing and maintaining ReVAMPP Network governance,
administration, and communication; and (Aim 2) accelerate transparent collaborative vaccine and antibody
strategy research by developing and maintaining a secure ReVAMPP Network Private Portal that includes
centralized resource, data sharing, and reporting systems. This independent, but integrated team of
administrators, communicators, and data science experts embedded within the ReVAMPP Network as the
CDSC, will coordinate, facilitate, and empower Network investigators and NIAID to proactively prepare to
rapidly share information with key stakeholders across the globe when new viral pandemic/outbreaks occur.

Public health relevance
PROJECT NARRATIVE NIAID is supporting the development of a new research Network comprised of a Coordinating and Data Sharing Center (CDSC) and Research Centers to collaboratively produce generalizable knowledge that enables rapid pandemic response to emerging viral pathogens. The overall goal of the RTI International-based CDSC is to establish and maintain an integrated Network to accelerate discovery and dissemination of novel vaccine and monoclonal antibody strategies to prepare for the next pandemic outbreak. This will be accomplished by leveraging RTI multidisciplinary experts and providing centralized administrative communication and operational support for Network-wide activities, while establishing data sharing and analysis standards and platforms.